Surface antimicrobial coating to prevent bacterial biofilms

Project Summary Implant medical devices are widely utilized as an essential support to patients. It is projected that many people will use at least one such device during their life time. However, there are medical issues with these devices such as bacterial infection. In particular, the formation of bacterial biofilms in implant medical devices further complicates the problem. Biofilms are bacterial communities that work together to escape the killing by the host or antibiotics. Currently, there is no treatment for such biofilms on medical devices and the last solution is to replace the infected ones. Such a replacement is costly and painful, however. Therefore, the objective of this proposal is to develop novel antimicrobial peptides and immobilization technologies that prevent bacterial biofilm formation on polymer materials of medical significance. Unlike traditional antibiotics, antimicrobial peptides remain potent after millions of years' evolution. We hypothesize that the immobilization of short antimicrobial peptides of varying activities can prevent biofilm formation on the polyethylene terephthalate (PET) surface. To test our hypothesis, we have designed the following specific aims: (1) To optimize the short antimicrobial peptide by sequence permutation; and (2) To immobilize the optimized peptide to the polyethylene terephthalate surface. We are well prepared to pursue this project. We have obtained preliminary results that support the feasibility of this research in the PI's laboratory. The anticipated outcomes of this R03 project are two fold. First, this project will lead to a family of short peptides with varying activity against superbugs. Second, the development of novel peptide immobilization technology will bring forth new possibilities to patients who are in need of new implant medical devices with improved properties. Finally, the project also provides an excellent training opportunity to the PI's postdoctoral fellow who will pursue an independent career in this direction.

Public health relevance
Project Narrative Implant medical device infection is extremely difficult to treat because of the formation of bacterial biofilms. The objective of this research project is to develop novel short antimicrobial peptides and peptide immobilization technologies that will allow us to modify the material surface to prevent biofilm formation.